Regulation and Localization of Mismatch Repair Proteins

Abstract:
An equipment supplement is requested to perform the experiments summarized below. This is
necessary to perform the experiments outlined in the parent grant. DNA mismatch repair (MMR) is a
highly conserved process. A functional MMR pathway is essential for maintaining genome integrity
and loss of MMR results in genome instability and cancer in higher eukaryotes. For example, defects
in MMR genes result in Lynch Syndrome, a common hereditary cancer syndrome resulting in early
onset cancers of the colon, endometrium, ovaries, small intestine, hepatobiliary tract, and upper
urinary tract as well as other tissues. In our most recent publication, we showed that deletion of
Modulator of Transcription (Not4) and General Control Nonderepressible 5 (Gcn5) modulate the
levels of MutSα (consisting of Msh2 and Msh6), the major complex involved in MMR. Not4 and Gcn5
are proteins that ubiquitylate and acetylate various proteins respectively. We hypothesize that these
proteins modify MutSα and that the modifications affect the stability and localization of the complex.
Further studies need to be conducted to gain a better understanding of how Not4 and Gcn5 regulate
these MMR proteins. Additionally, our previous experiments have shown that yeast MutSα is in the
vicinity of the replication machinery during DNA replication. Human MutSα interacts with the
replication machinery by binding PCNA and also recognizes specific histone modifications. How yeast
MutSα is recruited to chromatin remains elusive. Using the yeast Saccharomyces cerevisiae (S.
cerevisiae), this project aims to: 1) further examine the role of Gcn5 and Not4 in the regulation of
MutSα stability and 2) determine the effect of post-translational modifications on MMR protein
recruitment to chromatin.

Public health relevance
Project Narrative: DNA mismatch repair is a highly conserved process that functions to protect the integrity of the genome from prokaryotes to eukaryotes. In humans, defects in MMR results in Lynch syndrome, a cancer syndrome that results in colon and other types of cancers. The proposed project aims to provide further understanding of how MMR proteins are regulated and recruited to DNA, using the yeast Saccharomyces cerevisiae.